Computational Modeling-Informed Reward Subgroups in Adolescent ADHD

Although there is notable evidence for ADHD abnormalities in the brain's reward system, that evidence is
limited due to both its narrow focus on a limited number of reward constructs, as well as its inconsistencies
across studies. We believe the inconsistencies are the result of unrecognized ADHD neurobiological
heterogeneity. This project was designed to test the prediction that ADHD is a disorder where several, wholly
different types of neurobiological dysfunction are capable of producing the same ADHD diagnostic phenotype.
Clear, decisive evidence for such neurocognitively and neurobiologically distinct ADHD subgroups is needed to
support an emerging paradigm shift in ADHD neuroscience away from the assumption that every ADHD
patient has similar pathophysiology, to a multi-etiology model that ultimately should prove to have greater
translational usefulness. Here, we will focus on better understanding reward dysfunction in ADHD, which is
relatively under-studied compared to the other neurocognitive abnormalities often found in the disorder. We
propose to examine a large (n=200) sample of ADHD-diagnosed and non-ADHD (n=150) adolescents with an
ambitious reward-based phenotyping approach using a diverse reward test battery to assess numerous
domains of reward behavior (e.g., different types of reinforcement learning, valuation, cost processing, effort
expenditure, etc.) – an approach that proved highly successful in our preliminary ADHD study. This battery
also will leverage the advances in reward phenotyping made over the past decade by sophisticated
computational modeling of reward choice behavior and reaction time data. We then will map aspects of
individual differences in these abilities to frontostriatal network connectivity during reinforcement learning
`prediction errors.' Our ultimate goal is to use this information to classify ADHD patients into different
biotypes. Although our preliminary data suggest there likely are at least two different reward-impaired ADHD
subgroups with disparate profiles of reward dysfunction, our approach will be more rigorous than a simple
replication attempt. We will test the fit of broad conceptual models of ADHD neurocognitive abnormality for
the first time in the reward domain, then use those findings to refine our approach to biotyping individual
cases with rigorous classification methodology. The resulting biotypes will be validated using other fMRI
reward tasks. This project will create the most detailed and extensive database describing reward dysfunction
in ADHD to date, which we will make freely available to the scientific community to accelerate the pace of
discovery. A renewed, concentrated focus on reward dysfunction in ADHD is not just timely, but also likely to
set the stage for important advances in future etiological and translational research. Different types of ADHD
reward dysfunction could represent untapped new targets for novel intervention development, where
treatments are matched to the type of neurobiological dysfunction instead of the broad DSM ADHD diagnosis.

Public health relevance
This project will test a model of etiological diversity related to the brain's reward system in Attention Deficit/Hyperactivity Disorder (ADHD). Our detailed phenotyping will use test scores and metrics derived via computational modeling diverse forms of reward behavior in many different experimental contexts. Our biotyping analyses will characterize the expression of different profiles of reward behavioral and neural system dysfunction in ADHD. In addition to testing hypotheses with potentially paradigm-shifting significance for ADHD etiology and translational research, this project will create and disseminate an information-rich database resource of reward dysfunction in ADHD for widespread scientific community use.